Project 2: TMEJ Regulation in Cancer and Treatment Resistance

PROJECT 2 SUMMARY
Cancer cells frequently experience increased levels of replication stress, leading to the formation of DNA double-
strand breaks (DSBs) that require efficient repair mechanisms for survival. One such repair pathway, Theta-
mediated end joining (TMEJ) facilitated by DNA polymerase theta (Pol θ), is an error-prone process increasingly
relied upon by cancer cells relative to their normal cell counterparts. Pol θ has thus emerged as a promising
therapeutic target. Despite its potential, the specific replication-associated DNA damage substrates and genomic
contexts that necessitate Pol θ/TMEJ activity are not well understood. This project aims to fill these critical
knowledge gaps, enhancing our ability to exploit Pol θ inhibitors in cancer therapy. Aim 1 will elucidate the
molecular mechanisms of TMEJ recruitment to clustered interstrand crosslinks (c-ICLs), building upon
observations that a regulated homologous recombination (HR)-to-TMEJ handoff involving Rad51 ubiquitylation
is required. Aim 2 will identify modulators of Pol θ dependency in HR deficient cancer cells. Specifically, we will
examine the role of RNA/DNA hybrids and innate immune pathways in Pol θ synthetic lethality using genetically
engineered mouse models of BRCA-deficient breast cancer. Aim 3 will establish mechanisms of Pol θ-mediated
resistance to topoisomerase 1 (Top1) inhibitor-based antibody drug conjugates in HR proficient and HR deficient
patient-derived cancer models. Project 2 will synergize with mechanistic approaches and insights utilized across
all Projects in the Program and will be supported by the Administrative and Protein Expression Cores to reveal
new insights into how Pol θ can be most effectively targeted to improve cancer outcomes.

Public health relevance
PROJECT 2 NARRATIVE This project investigates the essential roles of Pol θ in resolving replication-associated DNA damage in cancer cells, aiming to elucidate mechanisms that drive therapeutic resistance. We will explore Pol θ's involvement in repairing clustered interstrand crosslinks, RNA-DNA hybrids, and topoisomerase 1-induced DNA adducts. By defining these roles, our research will identify new strategies to leverage Pol θ inhibitors to improve cancer outcomes.